High efficiency particulate air cleaner intervention to reduce respiratory virus exposure in elementary schools

PROJECT SUMMARY/ABSTRACT
There is a fundamental gap in understanding the extent to which the school environment contributes to
respiratory virus exposure, and less is known about effective environmental interventions to reduce exposure.
Our long-term goal is to create healthy indoor school environments for children. The overall objective of this
application is to identify environmental predictors of and potential interventions influencing respiratory virus
exposure in elementary schools. We will extend the robust infrastructure of the School Inner-City Asthma
Intervention Study (SICAS-2, ClinicalTrials.gov NCT02291302), a five-year randomized controlled trial
conducted by our group of a placebo-controlled classroom high efficiency particulate air (HEPA) cleaner
intervention to continue cohort recruitment in the post-COVID-19 pandemic period. We will test our central
hypothesis that modifiable built environment factors influence airborne respiratory virus exposure and infection
in elementary schools through the following specific aims: (1) To determine the efficacy of a randomized
placebo controlled HEPA cleaner intervention in reducing classroom airborne respiratory virus exposure; (2) To
determine the efficacy of a randomized placebo controlled HEPA cleaner intervention in reducing symptomatic
and asymptomatic respiratory viral infections in asthmatic children. The approach is innovative, because we
are simultaneously interrogating all major human respiratory viruses in the context of a school-based
randomized trial focused on an environmental intervention. The proposed research is significant, because if the
HEPA intervention can reduce respiratory virus exposure and infections in schools, it is an immediately
actionable and practical intervention to create safer indoor environments for elementary school children.
Results from this proposal may be generalizable to other public indoor settings.

Public health relevance
PROJECT NARRATIVE Schools represent a source of exposure to respiratory viruses, yet there is little data on factors that influence school respiratory virus exposure. The proposed research is relevant to the part of NIH’s mission to promote healthier environments by identifying factors predicting classroom airborne respiratory virus exposure including testing the efficacy of a high efficiency particulate air (HEPA) cleaner intervention in reducing classroom respiratory virus exposure and infection. We urgently need research to identify practical and evidence-based strategies to create safe indoor school environments for students.